Hepatocyte FOXA3 in Alcohol-Associated Liver Disease

Project Summary
Project Summary: Alcohol-associated liver disease (ALD) is the most prevalent type of chronic liver disease
worldwide. ALD represents a spectrum of liver disorders resulting from alcohol use, ranging from alcohol-
associated hepatic steatosis (i.e., alcoholic fatty liver) to more advanced forms, including alcohol-associated
steatohepatitis (ASH)/hepatitis (AH) and cirrhosis (AC). Alcohol-associated hepatic steatosis is the result of the
earliest response of the liver to alcohol abuse. So far, the mechanism underlying the pathogenesis of ALD
remains to be fully understood. There are also limited options for the treatment of ALD. Our preliminary study
shows that hepatic forkhead box A3 (FOXA3), a member of the winged-helix transcription factors, is reduced in
patients or mice with ALD. In this project, we will investigate the role of hepatic FOXA3 in the development and
progression of ALD. We will also characterize the underlying mechanisms. Gain- and loss-of-function
approaches and state-of-the-art techniques will be used to investigate whether hepatic FOXA3 is a key player in
the pathogenesis of ALD.

Public health relevance
Project Narrative Relevance: Alcoholic liver disease is one of the major causes of death worldwide. Completing this project may help identify hepatocyte FOXA3 as an important regulator of ALD and may lead to identifying hepatic FOXA3 as a new target for the treatment of ALD. Thus, this project is highly relevant to human health.